CHEMOPREVENTION OF NMU INDUCED MAMMARY TUMORS

The objective of this Master Agreement Order is to study the chemoprevention of MNU induced mammary tumors in the rat with selected chemopreventive agents.